Engineering a Middle Meningeal Artery Embolization Model with Hydrophilicity and Hydraulic Resistance

PROJECT SUMMARY
Chronic subdural hematoma (cSDH), a neurological disorder characterized by abnormal blood accumulation
the surface of the brain, is often treated by surgical evacuation of the blood. However, the recurrence rate of this
approach remains high (up to 20%). Data from recent randomized clinical trials demonstrate endovascular
treatment of cSDH via embolization of the middle meningeal artery (MMA) significantly reduces recurrence
compared to surgery. Thus, cSDH MMA embolization is poised to become standard of care, with the number of
procedures projected to surpass that of endovascular therapy for large vessel strokes. Positive outcomes with
cSDH MMA embolization have been demonstrated with existing embolic agents including polyvinyl alcohol
particles, Onyx and its derivatives, and n-butyl cyanoacrylate glues (regulatory approval of these agents
specifically for this indication is underway). At least two next-generation biomaterial embolic agents (NeoCast™
Embolic System and IMPASS™ Embolic Device) are also being developed for cSDH MMA embolization.
The rapid growth of cSDH MMA embolization highlights a need for a vascular bench model that trains
clinicians on the use of various embolic agents. The model will serve as an important first step in
neurointerventional education, especially for agents with steep learning curves. We have already developed a
first-generation, silicone MMA model using cSDH patient data. The model has multiple target sites for injection,
can be used under fluoroscopy, and allows angiographic occlusion assessment. Unfortunately, the hydrophobic
nature of silicone and absence of a capillary bed may alter the flow and distribution of an embolic agent; it also
precludes testing of liquid agents that occlude in a distal to proximal fashion (e.g., n-butyl cyanoacrylate glue
and NeoCast) as there is no backstop to prevent material flow-through. To address these issues, we propose to
enhance our model by more accurately replicating the in vivo environment. First, we will hydrophilize the silicone
model to have a water contact angle similar to blood vessels. This will be accomplished using either hydrogel
surface-coating or hydrophilic polydimethylsiloxane tethering techniques. Second, we will integrate a hydraulic
barrier (leveraging unique porous morphology of polyurethane foams) that creates fluid flow resistance (e.g.,
pressure drop) similar to that of a capillary bed and acts as a backstop to prevent material flow-through.
Experienced neurointerventionalists will perform injections in the improved model with PVA particles, Onyx,
and n-butyl cyanoacrylate. They will provide feedback on face validity (the resemblance of the model to real-life
scenario) and content validity (effectiveness as a training tool for cSDH MMA embolization). Subsequently,
embolization performance (e.g., ease of injection, injection time, embolic radiopacity, angiographic occlusion) of
NeoCast in the model will be compared to that of the existing agents. This project will deliver a robust bench
training model for neurointerventionalists to learn procedural skills and use of current and next-generation
embolic agents for cSDH MMA embolization, which will ultimately benefit patient care.

Public health relevance
PROJECT NARRATIVE Endovascular treatment of chronic subdural hematoma (cSDH) via embolization of the middle meningeal artery (MMA) is set to become the most prevalent neurointerventional procedure. We propose to develop a bench model of cSDH MMA embolization, which will serve as an educational tool for neurointerventionalists to learn and understand the behavior of various embolic agents used in this indication. Incorporating bench trainig models into neurointerventional education is important for advancing clinical research and enhancing patient care.